Affective and Genomic Mediators of Sustained Behavior Change

DESCRIPTION (provided by applicant): People's day-to-day behavioral choices - including how to respond to stress and whether to be physically active - accumulate and compound to set their health risks and life expectancies. Indeed, two of every five premature deaths in the U.S. can be linked to unhealthy and ultimately modifiable behavioral choices. Despite good intentions to improve their health, people's attempts at midlife lifestyle change often fail, paving the way to late-life health limitations and costly chronic conditions. The overarching goal of the proposed research is to investigate how positive emotions alter biological systems in ways that ultimately reinforce sustained positive behavior change. An innovative upward spiral model of lifestyle change integrates the science of positive emotions with the emerging field of social genomics to describe pathways through which positive emotions may influence gene expression to undergird sustained behavior change. Specifically, we propose that positive emotions trigger peripheral biological changes that alter inflammation-related gene expression in ways that increasingly and implicitly reinforce wellness behaviors. Two studies - spanning laboratory and field - test this new model by targeting three Specific Aims. These aims are: (1) to identify peripheral biological resources and genetic polymorphisms that moderate the link between wellness behaviors and their positive emotion yield; (2) to identify the biological signaling pathways that mediate the proposed association between increases in positive emotions and changes in inflammation-related gene expression; and (3) to investigate the pathways through which increases in positive emotions influence changes in inflammation-related gene expression, sustained wellness behaviors, and associated health outcomes. Study 1 is a controlled laboratory study that investigates whether candidate peripheral biological resources (i.e., oxytocin, respiratory sinus arrhythmia, blood pressure, and C-reactive protein) and inflammation-related genetic polymorphisms moderate the positive emotion yield of wellness behaviors and thereby fuel upward spirals of healthy lifestyle change. Study 2 complements and extends this laboratory study, by testing the full scope of the upward spiral model of lifestyle change using a longitudinal, randomized, dual-blind, placebo-controlled field experiment with repeated measures of peripheral biological and genomic markers. This rigorous and validated longitudinal design is unprecedented in human social genomics research and can illuminate how wellness behaviors and biological health mutually reinforce one another. This program of translational research stands to forge a unified science of behavior change, reshape public health interventions, and unlock hidden opportunities to promote healthy longevity.

Public health relevance
PUBLIC HEALTH RELEVANCE: Unhealthy behavioral choices contribute to costly late life chronic diseases and premature death. Sustained positive behavior change is thus vital to promote healthy longevity, yet remains elusive. Understanding how positive emotions alter gene expression in ways that implicitly reinforce long-term adherence to positive health behaviors is needed to unlock evidence-based health interventions to promote health and save money and lives. PROJECT NARRATIVE Unhealthy behavioral choices contribute to costly late life chronic diseases and premature death. Sustained positive behavior change is thus vital to promote healthy longevity, yet remains elusive. Understanding how positive emotions alter gene expression in ways that implicitly reinforce long-term adherence to positive health behaviors is needed to unlock evidence-based health interventions to promote health and save money and lives. __SpecificAimsTextDelimiter__ SPECIFIC AIMS People's day-to-day behavioral choices - including how to respond to stress and whether to be physically active - accumulate and compound to set their health risks and life expectancies. Indeed, two of every five premature deaths in the U.S. can be linked to unhealthy and ultimately modifiable behavioral choices.1 Despite widespread conscious awareness of the health risks associated with certain behaviors, sustained positive behavior change is difficult to achieve. A unified science of behavior change can be advanced by a deeper understanding of the underlying affective and genomic factors that drive and sustain behavior change at nonconscious levels. The PI's past work illuminates the substantial power of positive emotions to predict sustained behavior change: Individuals one standard deviation above the mean in their positive emotional responses to a newly-adopted wellness behavior were ~4.5 times more likely to maintain that behavior 15 months later, compared to those one standard deviation below the mean.2 The overarching goal of the proposed research is to investigate how positive emotions alter bodily systems in ways that ultimately reinforce sustained positive behavior change. Its innovation lies in uniting the PI's broaden-and-build theory of positive emotions3,4,5 with the emerging field of social genomics,6,7 an integration we dub positive social genomics. We propose that positive emotions influence gene expression to support sustained wellness behaviors by building personal and biological resources that increasingly and implicitly reinforce behavioral maintenance. The PI's newly articulated upward spiral model of lifestyle change expands on her broaden-and-build theory substantially by articulating key roles for (a) peripheral biological signaling pathways, such as oxytocin (OT), respiratory sinus arrhythmia (RSA), blood pressure (BP), and systemic inflammation, as indexed by C-reactive protein (CRP); (b) changes in inflammation-related gene expression; and (c) feedback loops that both raise the propensity for wellness behaviors and increase the positive emotion yield of those behaviors. Although this model applies to a range of wellness behaviors that can yield positive emotions (e.g., relaxation techniques, running, dance, yoga, cycling, nature walks), the present proposal provides an initial and rigorous test of the new model by capitalizing on an ancient wellness behavior, namely, meditation, which has been empirically- validated to reduce stress,8 pain,9 and depression,10 and alter trait affect.11,12 Two studies - spanning laboratory and field - compare the immediate and long-term effects of two different meditation practices: one concentration practice that teaches skills to self-generate warm-hearted positive emotions (loving-kindness meditation, LKM) and a second concentration practice that teaches skills to sharpen attention, devoid of efforts to cultivate positive emotions (mindfulness meditation, MM). The PI's past longitudinal experiments12,13 document that LKM increases trait positive emotions, builds personal and physical resources, which in turn promote improved health and well-being. The proposed work extends this past work by investigating affect- related changes in peripheral biological signals and gene expression that in turn reciprocally support positive emotional biology in the central nervous system. It translates basic science into a high-impact public health agenda that stands to shift clinical practice paradigms by positioning positive emotions not simply as pleasant correlates of wellness behaviors, but rather as the engine of sustained adherence to them. Whereas traditional health promotion efforts rest on building public awareness of health risks and appeals to effortful self-control, the proposed approach promises to break through existing barriers to progress in health promotion by harnessing nonconscious and biological-rooted positive emotion processes that unlock key genomic changes that motivate and sustain behavior change. A controlled laboratory study complements a field-based longitudinal, randomized, dual-blind placebo-controlled test of the health benefits of learning skills to self- generate positive emotions, offering a rigorous, longitudinal design unprecedented in human social genomics research. Combined, the proposed work targets three Specific Aims: Specific Aim 1: To identify peripheral biological resources and genetic polymorphisms that moderate the link between wellness behaviors and their positive emotion yield. Specific Aim 2: To identify the biological signaling pathways that mediate the proposed association between increases in positive emotions and changes in inflammation-related gene expression. Specific Aim 3: To investigate the pathways through which increases in positive emotions influence changes in inflammation-related gene expression, sustained wellness behaviors, and associated health outcomes.